Modeling and validating dynamic accessibility to healthcare with system science approach

PROJECT SUMMARY
In public health sciences, people’s accessibility to healthcare determines how easily they can reach and utilize
health services. For researchers and policy makers, modeling and measuring accessibility to healthcare is key
to narrowing disparities and achieving health equality. Each year, a plethora of research efforts aim to model,
estimate, and map geographic disparities in healthcare accessibility, informing targeted interventions in
underserved areas. These studies have predominantly adopted either a travel cost-based approach or supply-
demand approach to measure accessibility. Both approaches are population-based and temporally static,
assuming uniformity among individuals and disregarding temporal factors. The derived accessibility measures
fail to account for temporal variations, as well as heterogenous individuals and their interactions. To address
these limitations, I will propose new conceptual frameworks to model and validate accessibility to
healthcare using a system science approach. This two-year small project will study people’s access to
healthcare in a dynamic and social system that involves complex interactions among individuals, as well as
interactions between individuals and the environment (e.g., transportation network and health facilities). I will
pioneer two models in system science, namely the system dynamics model and the agent-based model, to
represent this system. I will implement these two types of models in the state of Florida in the context of recent
‘triplepidemic’ (flu, RSV and COVID) during 2022-23 season, and attempt to validate the model results. This
study will contribute to the literature by adding a time dimension, individuals’ heterogeneity, and their social
networks to the models of healthcare accessibility. Additionally, this study will investigate a novel method to
validate healthcare accessibility models, addressing a persistent gap in existing research. Researchers and
policy makers can use the newly developed tools to better monitor dynamics of healthcare accessibility and to
mitigate health disparities more precisely with spatio-temporally dependent intervention.

Public health relevance
PROJECT NARRATIVE Improving healthcare accessibility is a top national priority for the U.S. government over the next decade, aiming to reduce health disparities. Traditional measures of healthcare access have relied on population-based and static methods, assuming uniformity among individuals and disregarding temporal factors. This project adopts a system science perspective to pioneer individual-based and dynamic approaches, based on which researchers and policy makers can better capture dynamics of healthcare accessibility and design spatio- temporally targeted intervention.